Age-specific differentiation of multipotent progenitors

PROJECT SUMMARY/ABSTRACT
The foundation of this project is based on the clinical observation that adults and children are affected by
different blood disorders, many of which show typical age biases. Accumulating evidence supports the notion
that the scripted changes that occur normally in the hematopoietic system during development and aging
create transient, age-specific hematopoietic substrates in which these diseases develop. The blood forming
system undergoes a controlled maturation process wherein the prioritized lineage outputs, mechanisms of
lineage restriction, and rates of hematopoietic stem cell (HSC) self-renewal change from early development
through maturation of the organism. Postnatally, as the hematopoietic system ages, these changes continue
with a progressive myeloid bias and further diminishment of HSC self-renewal. These temporal changes in the
mechanisms of blood formation appear to be regulated both intrinsically and extrinsically, as both the anatomic
location and cellular composition of the hematopoietic microenvironment change with time in concert with the
function of HSCs. Our prior K08-supported research has identified a novel potential mechanism of epigenetic
control of the transition from the transient, juvenile state of hematopoiesis to mature adult hematopoiesis.
Here, we will investigate molecular mechanisms regulating the shifting lineage biases that occurs during
hematopoietic maturation.

Public health relevance
PROJECT NARRATIVE During normal mammalian development and aging, the hematopoietic system undergoes a controlled maturation process wherein hematopoietic stem and progenitor cells (HSPCs) execute dramatic transitions in in self- renewal and lineage biases. Understanding the molecular drivers of this process is important to investigation of age-specific blood disorders and hematopoietic stem cell transplantation. In this proposal, we aim to elucidate how HSPCs mature over time to meet the developmental and physiologic needs of the host and define new molecular mechanisms controlling the maturation of the blood forming system.